Quantitative and Computational Biology Graduate Program

Abstract: The proposed activities will continue the highly successful work of the multidisciplinary NHGRI PhD training program administered by Princeton’s Lewis-Sigler Institute (LSI) for Integrative Genomics. The program was established twenty years ago by David Botstein, a pioneer of genomics research and education. The main objectives are to train students in how to collect and analyze increasingly complex genomics data, broadly defined, and provide a thorough education in how to integrate genomics with mechanistic studies of living systems. We have updated the program and refined it in order to keep up with the technical and conceptual advances of modern genomics research. We have expanded the ability of trainees to work with a range of mentors from several graduate programs at Princeton University, including the Program in Quantitative and Computational Biology (QCB) and its partner departments. Now, trainees can do their lab rotations and thesis research with any of 24 affiliated faculty working on subjects as diverse as the design of novel genomic technologies, statistics of genomic datasets, data integration, and genomics of human diseases. Students have more seminar opportunities, are assigned peer and faculty mentors, and have greater opportunities to craft an interdisciplinary PhD topic. The trainees also have new opportunities within the recently established research and educational initiatives at Princeton, including the Omenn-Darling Bioengineering Institute and Princeton Precision Health, both of which are headed by two faculty mentors in our training program.
We request support for 10 pre-doctoral positions (i.e., maintaining our current level) per year. Each trainee is typically supported for a total of two years, with the remainder of funding coming from PIs’ grants and/or home departments. In addition to having access to the independently funded experimental and computing facilities of the LSI and partner departments at Princeton, trainees have opportunities to teach in an innovative undergraduate Integrated Science Curriculum, which continues to serve as a successful blueprint for quantitative education in the Life Sciences.

Public health relevance
Project narrative: The NHGRI training program administered by the Lewis-Sigler Institute for Integrative Genomics has been a pioneer in combining cutting edge research and graduate education related to the large-scale gathering, statistical analysis, and mechanistic interpretation of complex genomics datasets. The educational and research elements of the program are regularly updated, reflecting the fast pace of modern genomics and Princeton’s commitment to quantitative life sciences. In this application, we have also renewed and strengthened our efforts in the integration of modeling and experimental strategies of genomics research.